Southwest Oncology Group

The University of Rochester is a health and research institute ideally suited to help achieve the goals of the Southwest Oncology Group (SWOG). These goals include: improve standards of care to adult cancer patients advance the understanding of cancer biology via translational research, promote treatment and supportive care to outreach sites through NCI-supported clinica_ trial participation, explore innovative multi-modality treatment combinations, support cancer prevention efforts, and refine methodology of clinical cancer trials. Our long standing history (1978 - 2001) as NCI funded members of the Eastern Cooperative Oncology Group and current activity (2002 - to date) as funded members of the Southwest Oncology Group, indicates our continuous investment in and commitment to clinical and basic laboratory research, patient care, and education. In only one year, we have enrolled 71 cases (100% timely data submission) and served as study chair or co-chair of nine SWOG protocols; 2"/multidisciplinary members actively participated in one or more committees (two faculty members served as chair and/or co-chair of five committees). Seven faculty members coordinated two protocols to be activated and two studies currently in development. As we recruit more clinical-scientific faculty and further develop interactive, collaborative, multimodatity cancer programs, we plan to produce additional important contributions to SWOG. The University of Rochester SWOG program involves 4, the University's James P. Wilmot Cancer Center and the University's Strong Memorial Hospital, a primary tertiary care center. The Cancer Center and hospital serves a population of approximately 1.4 million people; t eight outreach facilities located in the regional Northeast section of the country (contiguous states of New York and Massachusetts). Through this Southwest Oncotogy Group application, our program proposes to support and attain its objective.' to t) participate in multi-modal Phase II/111clinical trials; 2) accelerate the advances of cancer therapy in adult patients through increased recruitment; 3) enhance basic science clinical interactions; 4) support cancer control and prevention initiatives; 5) provide wide dissemination of information through quality and timely data collection and publications; 6) continue service to the administrative agenda of the Southwest Oncology Groul: